The Role of Purinergic Signaling in Microglia Birth and Maturation in the Adult Brain

Project Summary. Microglia are the brain’s immune cells and have long been appreciated for their critical roles
during brain injury and disease. Recent studies, however, have demonstrated that microglia have important roles
in the absence of pathology and serve to maintain brain homeostasis, support developing neurons and aid in the
remodeling of neural circuitry during development and plasticity. This makes microglia a therapeutic target for
diseases in which neural circuits either develop or remodel inappropriately. Despite their importance in brain
health and disease, very little is known about how microglia self-maintain after they colonize the brain during
development. This knowledge is fundamental to understanding how microglia maintain their functions throughout
the lifespan. While microglia are long-lived cells, depletion methods have demonstrated that the adult microglial
population can be rapidly reconstituted by the proliferation of resident cells. Because these studies have been
carried out in fixed tissue the dynamics and mechanisms of this process are unclear. I propose to determine how
microglia are born and mature in vivo. I will also explore the role of the purinergic receptor, P2Y12 in this process.
I hypothesize that microglia are born by the division of single microglia and depend on purinergic
signaling to rapidly differentiate morphologically and functionally to perform their physiological roles in
the brain. In order to test this hypothesis, I will address two related but independent aims. In Aim 1, I have
started to test the hypothesis that microglia repopulate from rapid division of single surviving microglia under
normal conditions and after experimental depletion. I have also shown that microglia are critical to experience-
dependent plasticity in the adult visual cortex. In Aim 2, I will test the hypothesis that the physiological attributes
of microglia such as process motility and microglia-synapse interactions return to baseline soon after microglia
are born in the adult. I will also explore whether P2Y12 signaling contributes to the maturation of these attributes
in newly-born adult microglia. Lastly, I will examine how rapidly newly-born microglia acquire their functions that
support experience-dependent plasticity in the visual cortex. Together these two aims characterize how microglia
proliferate and maintain homeostasis in the adult cortex. Thus, this proposal embodies a new set of techniques
that allows the close monitoring of the self-renewal dynamics of microglia. The training I will obtain in graduate
school while performing the first to aims, will prepare me for my postdoctoral studies in Aim 3, where I will carry
out collaborative work to determine therapeutic targets for the treatment of neurodevelopmental disorders.

Public health relevance
Project Narrative. Understanding the dynamics of microglial self-renewal is important to defining the role of these highly dynamic cells in health and disease. This proposed research will use in vivo two-photon imaging in awake mice to track the turnover and repopulation dynamics of microglia after pharmacological depletion. Results from this study will expand on our understanding of microglial ontogeny and maturation in the adult cortex.